900 MHz NMR console and probes

PROJECT SUMMARY/ABSTRACT
Funding is requested to obtain a 900 MHz NMR Bruker Avance Neo console and cryoprobes to replace
our obsolete Varian/Agilent system at the University of Colorado School of Medicine. The existing console and
probes are over 17 years old and are now obsolete as Agilent has withdrawn from the NMR business. This 900
MHz instrument functions as a regional ultra high field NMR facility that serves the needs of users at multiple
institutions through the Rocky Mountain West region of the United States. There is no other NMR instrument
like it within 800 miles of Denver. In the last 10 years it has been used by 55 investigators from 20 institutions.
The long term objectives of this application are 1) to ensure access to state-of-the-art NMR instrumentation
and expertise in NMR spectroscopy for NIH funded researchers in the region, for the structural analysis of
biological macromolecules and their interactions; 2) to provide training in state-of-the art NMR approaches to
the next generation of biomedical researchers. The requested instrumentation provides enhanced sensitivity
and technical capabilities that will allow the implementation of modern NMR experiments for the study of
biological macromolecules in solution. This upgrade is essential to support the specific aims of NIH funded
research of the users of this instrument that include fundamental studies of biological macromolecular structure
and function, discovery of novel lead compounds for therapeutic interventions, to development of novel
techniques for NMR spectroscopy studies. The requested instrumentation meets our long-term objectives by
ensuring continued access for NIH funded researcher to the instrumentation required for their projects. This
new instrumentation will dramatically enhance research capabilities and research productivity, and provide
outstanding training opportunities to the next generation of biomedical scientists.

Public health relevance
PROJECT NARRATIVE The University of Colorado School of Medicine NMR facility houses 600 and 900 MHz NMR spectrometers for use by researchers at multiple institutions throughout the Rocky Mountain West region of the United States. The requested 900 MHz NMR console and probes will be installed on an existing Oxford 21 T magnet and replace the existing obsolete equipment. This new equipment will ensure that NIH funded researchers in the region continue to have access to the necessary instrumentation for their funded projects. that range from understanding basic concepts of biological macromolecular structure and function through to the discovery of novel lead compounds for therapeutic interventions in diseases including cancer and infectious disease.